Characterization of clinical phenotypes of laryngeal dystonia and voice tremor

PROJECT SUMMARY / ABSTRACT
Focal laryngeal dystonia (LD) is a rare neurological voice disorder that interrupts speaking with intermittent
onset of a strained-strangled voice quality or causes voicing to stop or produce sudden breathiness. Those
suffering from LD commonly report onset of symptoms 5 years prior to achieving an accurate diagnosis,
despite seeing multiple experts. Voice tremor (VT) is another neurological voice disorder that is perceived by
listeners as a shaky voice quality. Severe VT can result in voice interruptions that sound similar to LD resulting
in misdiagnosis by experts. Recent research shows poor reliability in distinguishing those with LD from other
voice disorders, largely due to the reliance on perceptual assessment methods and a wide range of clinical
criteria without evidence to guide accurate diagnostic approaches. This is particularly true of VT, a voice
disorder without clearly documented clinical features such that classification is not possible using current
movement disorder consensus-based tremor syndrome criteria. Accurate differential diagnosis of LD from VT
is essential to effective treatment planning and management as well as for accurate clinical and epidemiologic
characterization and classification. The goal of this project is to systematically characterize individuals
with LD and VT using currently available and novel clinical tools to determine distinguishing clinical
features highly predictive of their correct diagnosis. Three studies will be conducted with 65 individuals
each diagnosed by multi-disciplinary consensus to meet criteria for LD and VT as well as 35 neurotypical
normal controls. All participants will undergo thorough screening and testing to assure consensus regarding
their group assignment by experts from speech-language pathology, neurology, and otolaryngology.
Thereafter, clinical phenotypic features will be compared between groups using acoustic, aerodynamic,
laryngeal EMG, and nasoendoscopy to quantify periodicity and task-specificity of voice patterns. Novel
assessment tools and measures will also be used to study body distribution, condition of speech symptoms,
and regularity or intermittency/phoneme-specificity of speech structure movement (kinematic) patterns using
high speed videoendoscopy (HSV), real-time magnetic resonance imaging (rtMRI), and nasoendoscopy
recordings during sustained phonation compared to voice- and voiceless-loaded sentences. Computational
modeling will be used to assess aerodynamic, laryngeal EMG and speech structure kinematic patterns to
simulate patient-specific acoustic output predictive of group membership as VT or LD. Outcomes of this
research will significantly advance our clinical and scientific knowledge regarding optimal clinical tools and
measures of LD and VT clinical features that result in precise diagnosis of these neurological speech
disorders.

Public health relevance
PROJECT NARRATIVE This project will systematically evaluate current and novel clinical voice assessment tools and measures to elucidate distinct clinical phenotypes of those with laryngeal dystonia and voice tremor. Outcomes of this work will advance scientific knowledge about disorder-specific characteristics of laryngeal dystonia and voice tremor and advance evidence-based clinical assessment methods that increase the accuracy of diagnosis in those with LD and VT. Thus, the proposed research is relevant to NIH’s mission that pertains to developing fundamental knowledge that will help reduce the burdens of human disability.